Outreach Core

OUTREACH CORE:
The ST-Analytics scientific program is designed to take a systems biology approach towards addressing the question of how to effectively administer targeted-inhibitor – immunotherapy sequential combinations for the treatment of solid tumors, with an emphasis on melanoma. ST Analytics incorporates state-of-the-art experimental and computational programs advancing in close feedback with each other towards a robust solution. The ST-Analytics Outreach Program is designed as a highly complementary program, with STEM outreach goals that are aligned with the core scientific theme of the U54. The Outreach program takes advantage of ISB’s ‘Systems Education Experiences’ teacher Educational Programs that promote systems approaches to scientific problem solving through the development of educational modules that have provided positive STEM learning experiences for millions of students worldwide, and in each of the 50 states. A strong emphasis is placed on providing systems immuno-oncology internships and experiences to student populations representing every American in the STEM fields. The basic approach is to integrate these interns with ST-Analytics researchers to incorporate systems immuno-oncology concepts into two existing or in-development educational modules, entitled Systems Medicine Module 3 - Personalizing Disease Treatments, and Gaining Insight through Systems Thinking and Computational Modeling. While those modules are designed to meet Next Generation Science Standards (NGSS), the professional educators who are tasked with implementing those standards often do not have the proper background or supporting materials for the job. Thus, our outreach programs are also designed to provide that background and support. For example, we provide research-based, reality-driven professional development for more than 1,000 teachers and 80 district administrators annually, impacting over two-thirds of students in Washington. Thus, the potential impact of an ST-Analytics outreach program is large, and is achieved by leveraging extensive existing resources and relationships that extend throughout the state of WA and up and down the U.S. west coast. A program that solicits creative engagement from all participants within our proposed U54 program at all levels is described.